Intervening to improve HIV treatment and reduce drinking in young, black men who have sex with men

Significance. In the US, young, black men who have sex with men (YBMSM) are disparately impacted by HIV.
For many YBMSM, heavy drinking or problems related to alcohol use adversely impacts their HIV care and
treatment. Thus, interventions to improve HIV treatment outcomes and reduce heavy drinking in HIV-infected
YBMSM in HIV treatment are urgently needed. Career Development Plan. Dr. Knox's training will include
developing critical skills in intervention research and implementation science, and substantive training in HIV
care and treatment. This will be achieved through a plan that includes seminars, workshops, coursework,
conferences, and tailored mentoring. These activities will help Dr. Knox become an independent investigator
with a research program focused on understanding and addressing HIV and alcohol use in vulnerable
populations. Research Plan. In Aim 1, Dr. Knox's proposed research involves conducting formative work to
inform the development of an intervention that addresses HIV treatment and alcohol use in heavy-drinking, HIV-
infected, YBMSM. The intervention will borrow components from two distinct and potentially complementary,
evidence-based clinic-based interventions that are brief and theory-driven. The first improves HIV treatment
outcomes in HIV-infected YBMSM by involving a member of their social network to support them in HIV care.
The second intervention addresses alcohol use by using smartphone technology to engage participants daily in
self-monitoring relative to drinking reduction goals formed during a brief, motivational component of the baseline
intervention session. In Aim 2, the information from this formative work will be synthesized with the help of
consultant workgroups made up of YBMSM and implementation partners. The product of Aims 1 and 2 will be
an innovative intervention that leverages both social network support and technology to improve HIV treatment
outcomes and reduce alcohol use in heavy-drinking, HIV-infected YBMSM. It will be administered as a single-
session baseline intervention with brief follow-up check-ins. In Aim 3, the new intervention will be pilot tested to
assess its potential efficacy, acceptability, feasibility and implementation against a randomly assigned control
condition among 60 heavy-drinking, HIV-infected YBMSM in an HIV clinic in New York City (NYC). As an
epicenter of the HIV epidemic, interventions for young, black MSM in HIV treatment are urgently needed in NYC.
The results of this pilot test will inform the development of an R01 proposal for a fully powered randomized
controlled trial to evaluate the efficacy and implementation of the developed intervention. Mentorship. A team of
expert investigators in alcohol and drug use, HIV, racial and sexual minorities, intervention development,
implementation science and mixed methods will support this research. Public Health Impact. The project aims
to reduce disparities in HIV treatment outcomes and, in turn, incidence of new HIV infections, a high research
priority of the NIH Office of AIDS Research. Developing HIV interventions targeted for critical, underserved
populations also works towards achieving important End the HIV Epidemic milestones.

Public health relevance
Young, black men who have sex with men in the US are disparately impacted by HIV, and there is an urgent need for interventions that support these men in HIV treatment, especially those who drink heavily. The proposed project will develop an intervention that leverages social network support and electronic mobile technology to reduce alcohol use and improve HIV treatment outcomes that will then be evaluated against a randomized control condition in a pilot trial among 60 young, black men who have sex with men in an HIV clinic in New York City. The project aims to reduce disparities in HIV treatment outcomes and, in turn, incidence of new HIV infections, a high research priority of the NIH Office of AIDS Research, and an important step towards achieving End the HIV Epidemic milestones.